Cannabis and Pathogenic Mechanisms influencing Blood Brain Barrier Function in HIV

People with HIV (PWH) remain vulnerable to central nervous system complications (e.g., neurocognitive
impairment) despite antiretroviral therapy (ART) that suppresses viral replication. While many etiologies of these
complications exist, damage to the blood-brain-barrier (BBB), inflammation, and mitochondrial dysfunction are
consistently implicated, yet seldom studied simultaneously. PWH also use cannabis more frequently than the
general population and recent evidence by our group and others indicates that cannabis may protect PWH from
BBB damage by reducing inflammation and promoting mitochondrial homeostasis. The proposed
multidisciplinary, translational project will combine a clinical observational study with two preclinical models: a)
a technologically advanced brain chip model for BBB and b) personalized ex vivo/in vitro modeling of
mitochondrial toxicity in BBB cells to determine the effects of cannabis use on the BBB in PWH. Using this
multilevel approach, we will test the hypothesis that cannabis effects on the BBB vary based on patterns of use:
moderate use will be associated with beneficial effects, due to the anti-inflammatory properties of cannabis, but
chronic daily use will have detrimental effects. In a cohort of PWH and people without HIV (PWoH) across a
range of cannabis use from naïve to daily users, we will measure in plasma and cerebrospinal fluid (CSF) a
panel of biomarkers that reflect the BBB, inflammation, and mitochondrial dysfunction. These readouts will be
correlated with advanced permeability and multicompartment diffusion magnetic resonance imaging that will
identify global and regional variations in BBB leakage along with neuronal and glial microstructural properties
(Aim 1). We will model the BBB using 3D microfluidic cultures of brain endothelial and parenchymal cell subsets
to measure the effects of HIV and cannabinoids on BBB permeability, inflammatory gene expression, and
markers of mitochondrial function (Aim 2). Because responses to HIV and cannabis are often specific to
individuals or groups of individuals, we will use monocyte-derived macrophages and sera from the PWH and
PWoH in the observational study to determine the effects of cannabis (and HIV) on BBB cellular components
(astrocytes and endothelial cells), and on mitochondrial function, inflammatory gene expression, and BBB
biomarker gene expression (Aim 3). Thus, the proposed project will provide innovative clinical readouts in a
unique cohort alongside state-of-the-art modeling of the BBB and personalized investigation of pathogenic
mechanisms. This highly innovative, multidisciplinary research proposal is very likely to generate impactful
translational knowledge regarding mechanisms of pathogenesis and guide future therapeutic interventions. With
our combined clinical and pre-clinical expertise in HIV infection, substance abuse, BBB biology and imaging, and
mitochondrial homeostasis, we are uniquely suited to perform the proposed research.

Public health relevance
NARRATIVE Addictive drugs, including cannabis, can alter the structure and function of the blood-brain barrier (BBB), which helps protect the brain from the adverse effects of inflammation. These changes influence the risk for cognitive and mood disorders, particularly among vulnerable people with HIV. This project aims to combine multidisciplinary observational and mechanistic data to determine how cannabis and HIV combine to affect the BBB, inflammation, and the brain, which should provide valuable insights into the mechanisms underlying these relationships that may lead to new therapies and reduce the public health impact of these conditions.